Noninvasive Neuromonitoring to Guide Hemodynamic Optimization of Cerebral Perfusion After Return of Spontaneous Circulation in a Swine Model of Cardiac Arrest

PROJECT SUMMARY
More than 500,000 people in the United States suffer a sudden cardiac arrest (CA) each year, and most
successfully resuscitated patients ultimately die from hypoxic ischemic brain injury. Given the substantial
neurologic morbidity and mortality in patients who remain comatose following resuscitated cardiac arrest, there
is a critical need to identify therapies and treatment strategies to reduce neurologic injury in these patients.
Cerebral perfusion is an important contributor to neurologic outcomes in resuscitated CA patients who remain
comatose following return of spontaneous circulation (ROSC). Therefore, the ability to continuously monitor
cerebral perfusion and personalize treatment based on individual perfusion targets is essential. The objective of
this proposal is to create a swine cardiac arrest model, and to determine the impact of using cerebral
autoregulation-based vs standard MAP targets on cerebral perfusion and neurologic injury. In additional to
continuous optical monitoring of cerebral perfusion using diffuse correlation spectroscopy and of cerebral
oxygenation using frequency domain near infrared spectrometry, we will invasively monitor tissue oxygenation
and perfusion and also obtain 6 hours post-arrest CT scans to evaluate structural measures of tissue injury to
confirm optically observed perfusion changes using iodine bolus dynamic scan sequences. Neurological
outcomes and neural injury serum biomarkers will be assessed 24 hours post-arrest. We hypothesize that the
use of real-time noninvasive measures of cerebral autoregulation (using DCS) to identify and target an
individualized optimal MAP (MAPOPT) will improve cerebral perfusion and decrease neurologic injury after a
resuscitated cardiac arrest.

Public health relevance
PROJECT NARRATIVE Among patients who are successfully resuscitated after a sudden cardiac arrest, brain damage due to lack of oxygen during the arrest often leads to poor outcomes including death. Thus, there is a critical need to identify treatment strategies to reduce brain injury in these patients. In this study we will use a piglet model of cardiac arrest in combination with a novel, non-invasive method for continuous optical monitoring of brain blood flow to assess standard vs. personalized strategies to ensure sufficient brain oxygen delivery after resuscitation.